RESTORE (Recovery and Engagement for STimulant users On Re-entry)

Project Summary/Abstract:
Stimulant use (cocaine/ methamphetamine) has a major impact on HIV transmission and acquisition. Justice-
involved individuals are more likely to have stimulant use disorders and be at risk or living with HIV than the
general population, face interruptions in HIV treatment (antiretroviral therapy (ART)) and have limited access to
HIV pre-exposure prophylaxis (PrEP). There is thus a critical need for effective interventions that reduce
stimulant use and potentially improve HIV viral suppression (VS) and PrEP initation and retention, particularly
among justice-involved groups. The most successful treatment for stimulant use disorder to date is contingency
management (CM), shown to reduce stimulant use and HIV risk behaviors, though implementation has been
limited for justice-involved people due to competing priorities (transportation, housing, probation) and practical
challenges of providing CM (frequent drug testing, trained staff, incentive management). DynamiCare is an FDA-
approved mobile app that delivers patient-centered behavioral CM and has been shown to reduce biological and
self-reported assessments of stimulant and other substance use, however it is unknown if it could improve
PrEP/ART initiation for persons with stimulant use disorder at risk or living with HIV. Thus, in response to NIDA
RFA-DA-23-008: Stimulants and HIV, we propose the RESTORE study: Recovery and Engagement for
Stimulant Users on Re-entry. Guided by the Exploration Preparation Implementation Sustainment (EPIS)
framework, we will assess if the addition of personalized CM via the DynamiCare app to a previously protocolized
patient navigator (PN) (“DynamiCare-plus”) intervention improves initiation of PrEP/ART and reduces stimulant
use. The Specific Aims are: Aim 1 (R61): To conduct a pilot assessment of DynamiCare-plus for persons at
risk or living with HIV with DSM-5 stimulant use disorders (methamphetamine/cocaine) being released to the
community from a closed justice setting (jail/ prison/ justice-mandated substance use program). N=40 adults in
Dallas, TX and CT will be randomized 1:1 to DynamiCare-plus compared to enhanced treatment as usual (ETAU)
(PN + smartphone) for 6 months to assess acceptability, feasibility and preliminary effectiveness: proportion who
(1) initiate PrEP/ART; and (2) achieve/maintain VS (VL < 200 copies/mL) for those with HIV; Aim 2 (R33): The
R61 pilot will inform a type 1 hybrid implementation effectiveness randomized controlled trial of DynamiCare-
plus v. ETAU among 252 participants with the same eligiblity as the R61 to assess the primary outcome of
initiation/reinitiation of PrEP/ART followed for 15 months, with a 12 month intervention period. Secondary
outcomes include stimulant and other substance use, overdose, PrEP/ART/SUD retention, HIV risk behaviors,
VS, Quality of life, and recidivism; Aim 2.1: Examine implementation of the intervention. Aim 2.2: Conduct cost
analyses of the intervention compared to control. The Dynamicare app is mobile, adaptable and scalable, and
combined with PN (DynamiCare-plus) has the potential to have a major impact on HIV treatment and prevention
for justice-involved people with stimulant use disorder.

Public health relevance
Project Narrative: This specific NIDA R61/ R33 mechanism provides an ideal opportunity to assess the ability of an FDA- approved individualized mobile app, DynamiCare, to deliver personalized treatment of stimulant use disorder with the most effective form of treatment, contingency management, to individuals at risk or living with HIV as they navigate the reentry period after justice system involvement. The main hypothesis is that an effective treatment for stimulant use disorder, contingency management, which provides financial incentives for abstinent substance tests, treatment attendance and completion of therapy modules, delivered to them on their mobile phone and paired with a personal patient navigator, could reduce relapse to stimulant use and improve initiation of PrEP for those at risk of HIV and uptake/ retention on ART for those living with HIV.